Investigating the role of TET deficiency in promoting T cell expansion and inflammation

Abstract
DNA cytosine methylation (hereafter, DNA methylation) has a critical role in cell lineage specification as well as
suppression of repetitive and transposable elements in the genome. DNA methyltransferases attach a methyl
group to generate 5-methylcytosine (5mC); TET methylcytosine dioxygenases cause DNA demethylation by
oxidizing the methyl group of 5mC to 5-hydroxymethylcytosine (5hmC) and beyond. We have shown that TET-
deficient cell types display not only the expected increase in DNA methylation at promoters and enhancers, but
also a paradoxical decrease in DNA methylation in heterochromatic regions of the genome. The consequences
of these molecular features remain to be understood, but similar alterations in genome-wide DNA methylation
patterns have been observed in cancer and aging.
By studying the phenotypes of several mouse strains in which Cre recombinase was expressed either inducibly
or developmentally in immune/ hematopoietic cell types, we showed that deletion of two or more Tet genes
skewed cell lineage commitment in the relevant cell type, in a manner that correlated with changes in cell lineage
commitment. More striking phenotypes, however, were that Tet2/3 fl/fl CD4Cre mice displayed massive TCR-
dependent expansion of iNKT cells; and that Tet2/3 fl/fl Foxp3Cre mice developed a dominant proinflammatory
phenotype observed in heterozygous female mice, in mixed bone marrow chimaeras, and in immunocompetent
recipients injected with total CD4+ T cells from Tet2/3 fl/fl Foxp3Cre mice. This phenotype differs markedly from
that observed in heterozygous Foxp3+/- females and in immunocompetent mice injected with Foxp3-deficient
cells, which do not develop disease. In Aim 1, we will address the mechanisms underlying the striking expansion
of Tet2/3-deficient iNKT cells by using adoptive transfer approaches in vivo and recently-developed cell culture
systems that recapitulate the expansion in vitro. In Aim 2, we will ask whether the dominant autoimmune/
inflammatory phenotype of Tet2/3-deficient T regulatory cells requires, directly or indirectly, the decreased DNA
methylation in heterochromatin observed in every TET-deficient cell type examined so far. Decreased DNA
methylation in heterochromatin results in “heterochromatin dysfunction”, an aberrant cellular condition linked to
autoimmune/ inflammatory disorders, cancer, aging, and neurodegenerative diseases, that stems from aberrant
expression of transposable elements (TEs) and resulting DNA damage. DNA damage provokes “sterile
inflammation”: activation of innate immune sensing pathways for RNA and DNA with consequent upregulation
of type I interferons, interferon-induced genes and proinflammatory cytokines (e.g. IL-1b, IL-6, IFNg, IL-17)
Our proposed experiments will add to our knowledge of how TET proteins influence T cell expansion and T
regulatory function. More broadly, they will enhance our general understanding of the links connecting TET
deficiency and TE expression with autoimmune/ inflammatory diseases, clonal hematopoiesis, a premalignant
syndrome of older individuals associated with inflammation and cardiovascular disease, and cancer.

Public health relevance
Narrative T cells are a class of immune cells that fight diseases and cancer, whereas regulatory T cells (Tregs) are an opposing class that are essential to prevent autoimmune disease and rejection of organ or bone marrow transplants. Our project aims to understand how DNA methylation and demethylation affect T cell expansion and regulatory T cell function. This may give us new methods for improving how T cells and regulatory T cells function in the body to improve the efficacy of patient treatment.